POST STRESS LEFT VENTRICULAR CONTRACTILE DYSFUNCTION

Relation Between Regional Contraction and Perfusion During Stress and 15 to 45 Minutes After Stress in Ischemic and Nonischemic Myocardial Regions We wished to determine how quickly stress-induced changes in MBF and contractile function subsided following cessation of stress. For this purpose, 10 normal volunteers and 7 pts with CAD and normal resting LV function (mean LVEF=50+/-6%) were studied. All 7 pts exhibited stress-induced wall motion abnormality (WMA). The 17 subjects underwent gated blood pool (GBP) and positron emission tomography (PET) with O-15 water. GBP and PET images were acquired at rest, during stress (supine bicycle exercise or dobutamine), and approximately 15-45min post-stress. CAD pts also underwent stress thallium (Tl) scintigraphy and data were analyzed in 9 regions per subject. All ischemic regions on stress Tl also exhibited stress-induced WMA. However, none of the abnormal regions exhibited post-stress persistent dysfunction. Mean absolute regional MBF (ml/min/g) computed from the dynamic O-15 water data follow. CAD pts rest stress 15min-post 30min-post ischemic 0.90+/-0.08 1.25+/-0.14* 0.99+/-0.05 0.90+/-0.07 nonisch 1.03+/-0.07 1.79+/-0.18** 1.10+/-0.08 1.08+/-0.09 Normal volunteers normal 0.95+/-0.08 2.10+/-0.31** 1.17+/-0.15 1.00+/-0.08 *p<0.05 and **p<0.01, rest vs stress MBF was similar in ischemic, nonischemic and normal regions at rest. With stress, MBF increased in normal and nonischemic regions by 122% and 73%, respectively while the increase in MBF in the ischemic regions was attenuated (38%). MBF returned to baseline 15min and 30min post-stress in all groups. These preliminary data suggest that in pts with CAD and normal resting LV function, stress-induced perfusion and WMAs return quickly to baseline after the termination of stress.